Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core of our Liver Cancer in American Indians and Alaska Natives and Disparities (Li-CAD)
P20 program will serve to optimize the work of discovery conducted by the P20 Projects and Cores through
administrative support, enhancement of communication, data dissemination and structured oversight. The
Administrative Core will provide guidance and enhance communication for and between the following groups:
• Li-CAD Executive Committee
• Li-CAD External and Internal Advisory Boards
• Participating Institutions (University of Washington [UW]; Fred Hutchinson Cancer Research Center
[FHCRC]; Alaska Native Tribal Health Consortium [ANTHC]; Cherokee Nation Health Service [CNHS];
University of Texas Southwestern [UTSW]; Kumamoto University, Japan)
• AI/AN Leadership Council (ANTHC and CNHS)
• Discovery Team (Research Projects; Developmental Research Program; Biorepository; Biostatistics)
• Education and Advocacy Team (AI/AN Advocacy Committee, Education and Conference Committee;
Career Enhancement Program)
• National Institutes of Health (NIH) and National Cancer Institute (NCI) representatives
The Li-CAD P20 is comprised of a unique collaboration of multiple entities (Figure 1). Investigators from each
entity have demonstrated prior success in collaborative research and will partner in this program to establish
the infrastructure to develop a highly innovative, productive and significant program of discovery whose aim it
is to reduce disparities in liver cancer outcomes among Alaska Native and American Indian people. The Core
has the following Specific Aims:
Specific Aim 1: To provide the organizational structure for supporting the key objectives of the Li-CAD P20 and
to promote AI/AN-appropriate research objectives, community involvement and dissemination of findings
Specific Aim 2: To integrate the Li-CAD P20 with the host institutions (UW, FHCRC, ANTHC, CNHS and
UTSW) and AI/AN Tribal and Research organizations at ANTHC and CNHS.
Specific Aim 3: To provide oversight for the Li-CAD P20 Program Research Projects and Cores through
structured and transparent evaluation of all P20 Program activities and prepare the transition to P50 SPORE.

Public health relevance
While deaths related to lung, breast, prostate and colorectal cancer have declined dramatically by 40-53% between 1990 and 2016, hepatocellular carcinoma (HCC) is the only major malignancy whose mortality is rising in both men and women and has had the highest average annual percentage change. American Indian/Alaska Native (AI/AN) people face a disproportionally high burden of HCC with 2.4 times higher HCC incidence and 2.5 times higher HCC-related mortality than white persons. Our aim is to apply novel, innovative, translational approaches to surveillance and early detection of HCC that are informed by unique aspects of HCC pathophysiology and epidemiology in AI/AN people in order to eliminate disparities, improve early detection and ultimately reduce HCC-related mortality.